mRNA-encoded Cas13 as a pan-respiratory antiviral

Project Summary
There are over 200 viruses known to infect humans and they contribute to 6.6% of global mortality. We have
approximately 91 drugs for 10 viral species and vaccines for only 16. Reassortment and antigenic changes pose
challenges to vaccine efficacy; this has clearly been demonstrated during the COVID pandemic. Current drug
development is focused on small molecules and neutralizing antibodies, which require high doses or frequent
re-dosing to obtain functional outcomes and have also been challenged by antigenic changes. Thus, it is crucial
to address the need for higher efficiency and broader spectrum antivirals. To address this need we are proposing
an entirely different paradigm for antiviral development, an mRNA-encoded activatable RNase, Cas13, as a
platform for a pan-respiratory treatment. Cas13 represents a programmable RNase that can directly target and
degrade multiple viral messenger or genomic RNA. Synthetic mRNA is being used to deliver the RNase, as it
allows for transient, non-viral delivery, with an improved safety profile over other gene therapy vectors1. Given
achieving pan-respiratory results with a single mRNA-encoded Cas13 based drug is not trivial, critical steps
towards that goal can be achieved by focusing on the three most impactful respiratory viruses in circulation,
RSV, influenza and SARS-CoV-2. To date, our team was the first to demonstrate efficacy of mRNA-encoded
Cas13 in vitro and in vivo via nebulizer-based lung delivery against influenza in the mouse model and SARS-
CoV-2 in the hamster model in our recent publication in Nature Biotechnology. In order to achieve one drug for
RSV, influenza and SARS-CoV-2 there are important questions/challenges that will need to be met. Thus, we
will determine the optimal Cas13 species for multiple respiratory pathogens and investigate the mechanism of
action of Cas13 for each virus. We will also demonstrate single drug efficacy against RSV, influenza and SAR-
CoV-2 in vivo in mouse and hamster models, given as treatments for the individual viral infections, during co-
infection (influenza and SAR-CoV-2), and to mitigate transmission of SARS-CoV-2.

Public health relevance
Narrative The overarching goal of this application is to develop a single “pan-respiratory” mRNA-encoded Cas13 drug for treating viral respiratory infections, but with a focus on the three most impactful respiratory viruses in circulation, RSV, influenza and SARS-CoV-2. Multiple Cas13 nucleases will be evaluated, and mechanisms of action investigated; efficacy will be demonstrated with all three pathogens in rodent infection, co-infection and transmission models. Overall, we feel this approach and RNA-based platform have the potential to alter the paradigm for how viral infections are treated.